A Research Community Hub and Data Resource for Integrated Neuropathological and Omics Analysis of Alzheimer's disease.

ABSTRACT (DATA CORE)
The Seattle Alzheimer’s Disease Brain Cell Atlas (SEA-AD) project aims to create an AD/ADRD atlas and community data
hub that builds on transformative brain atlasing efforts of the BRAIN Initiative Cell Atlas Network (BICAN) in the
neurotypical brain to gain a deep understanding of AD pathology and disease progression. The Data Core team will build
a valuable and catalytic community cell atlas describing the cellular and molecular changes occurring in Alzheimer’s
Disease. It will organize and standardize the massive, multimodal datasets generated by SEA-AD2.0, using pipelines, data
models, databases, and the security of the cloud-based Allen Institute Brain Knowledge Platform (BKP), to support access
and communication across sites. The Dara Core will perform cross-project and cross-site integrative computational
analysis, extending the primary analyses occurring within the SEA-AD2.0 Projects. This work will focus on creating models
of disease progression through analysis of multi-site, multi-modality data from Projects 1-3, which will enable
characterization of affected cell types in AD and AD/ADRD donors. To maximize community impact, the Data Core will also
establish an Integrative Analysis Center (IAC) to foster joint analysis of single cell genomics datasets and associated
representations of disease pathology across the AD/ADRD community through data harmonization and mapping all data
to highly annotated BICAN/SEA-AD cell classifications. Finally, the Data Core will produce a public data hub and knowledge
base to enable the research community’s access to the SEA-AD Consortium’s data on the molecular and cellular hallmarks
of AD and AD/ADRD.

Public health relevance
PROJECT NARRATIVE (DATA CORE) The SEA-AD Data Core team will build a valuable and catalytic community cell atlas describing the cellular and molecular changes occurring in Alzheimer’s Disease. The team will organize and standardize the massive, multimodal datasets generated by the project, using pipelines, data models, databases, and security of the cloud-based Allen Institute’s Brain Knowledge Platform (BKP) to support access and communication across sites. The Data Core will organize and perform cross-project and cross-site integrative computational analysis to produce a public data hub and knowledge base about molecular and cellular hallmarks of AD and AD/ADRD progression.